Implementing a Scalable Smoke-free Home Intervention in Armenia and Georgia

SUMMARY/ABSTRACT
Among the disparities faced by populations in low- and middle-income countries (LMICs) are those related to tobacco use
and secondhand smoke exposure (SHSe). Two countries particularly impacted by tobacco use and SHSe are Armenia
(AM) and Georgia (GE), which represent the 11th and 6th highest smoking rates in men globally (51.5% and 55.5%,
respectively). However, smoking prevalence is much lower among women (1.8% and 7.8%). Notably, a primary source of
SHSe among children and most nonsmoking adults in many LMICs, including AM and GE, is the home. Smoke-free
homes (SFHs) can reduce SHSe, promote cessation, and possibly disrupt initiation; however, 61.4% of households in AM
and GE allow smoking in the home. Thus, promoting SFHs may be an innovative and relatively untapped strategy for
chronic disease prevention in these countries – and in other LMICs with high smoking rates. Research focused on
implementing evidence-based interventions (EBIs) offers unique opportunities to address the pressing needs in LMICs
and to examine key barriers in the adoption, scale-up, and sustainment of EBIs in low-resource settings. This proposal
builds on ongoing collaborations among MPIs Berg and Kegler, the GE National Center for Disease Control (NCDC), the
AM National Institute of Health (NIH), and the American University of Armenia (AUA), dating back to 2013. These
collaborations have established: 1) a strong community-based infrastructure for implementing public health programs
using local coalitions in 14 communities, developed in our current Fogarty-funded R01; and 2) a theory-based SFHs
intervention, designed to be brief and adaptable and shown to be effective, generalizable, scalable, and cost-effective
among low-income households in the US. The current proposal will strategically capitalize on our strong partnerships
with national public health agencies, local community mobilization infrastructure, and SFH EBI to address our specific
aims. Aim 1: We will adapt our SFH intervention to be culturally appropriate for the AM and GE populations, using a
community-engaged approach and robust adaptation frameworks and methods, and develop in-country capacity for
intervention dissemination (via local coalitions) and delivery (via national quitlines). Aim 2: We will examine the
effectiveness of the adapted intervention (vs. control) on SFH adoption (primary outcome) among households in AM and
GE, using a type 1 hybrid effectiveness-implementation RCT (n=550 participants; 275/country), with follow-up
assessments at 3 and 6 months. Aim 3: We will assess intervention reach, adoption, implementation, and maintenance
potential, as well as related contextual influences, using a mixed-methods process evaluation guided by RE-AIM. Our
team (including national public health agencies) will use these findings to develop a sustainability and dissemination plan
(e.g., intervention packaging for scale-up). This work will provide a robust model for adapting and implementing this EBI
for AM and GE, which could then be used for this intervention in other countries and/or for other behavioral targets and
EBIs in AM, GE, and elsewhere. This work will advance our long-term goals of building the knowledge base informing
strategies to reduce tobacco-related disparities globally and the implementation and scale-out of EBIs in LMICs.

Public health relevance
PROJECT NARRATIVE Tobacco use and secondhand smoke exposure (SHSe) represent critical health disparities in low- and middle-income countries (LMICs); Armenia (AM) and Georgia (GE) represent the 11th and 6th highest smoking rates in men globally (51.5% and 55.5%, respectively), but have low rates of smoking in women (1.8% and 7.8%) and few smoke-free homes (SFHs; 38.6%), which can reduce SHSe and tobacco use rates. This proposal builds on our ongoing collaborations with national public health organizations in AM and GE and advancements in local public health infrastructure; we aim to adapt our team’s evidence-based SFH intervention for homes in AM and GE, develop capacity to deliver the intervention via local community partners and the national quitlines, and test the intervention in a hybrid effectiveness-implementation RCT. This work will advance our long-term goals of building the knowledge base informing strategies to reduce global tobacco-related disparities, as well as the implementation and scale-out of evidence-based interventions in LMICs.